Precision Medicine in Cochlear Implantation: Leveraging Artificial Intelligence and Novel Variables for Performance.

PROJECT SUMMARY / ABSTRACT
The goal of the proposed research is to develop and validate a reliable clinical decision support tool (e.g.
prediction model) for early risk stratification for cochlear implant (CI) speech perception performance. Hearing
loss (HL) is the fourth most common disability worldwide, it considerably affects a patient’s quality of life (QOL),
directly linked to cognitive decline, and it poses an enormous financial burden to society (~$980 billion/year).1
CI has become the standard of care for patients that no longer benefit from hearing aids. However, despite the
enormous success of CIs, there is a wide inter-individual variability with respect to clinical and biological features
and their impact on post-implantation speech perception performance. The heterogeneity in CI performance
outcomes is a pervasive challenge for clinicians and families, as the management of poor CI performers is largely
reactive, without reliable clinical decision support tools for early risk stratification and/or prognostic assessment
at time of CI. If available, such predictive models would provide critical opportunity for risk stratification to
improve patient counseling, recommendations for auditory rehabilitation, considerations of device-related
underperformance (e.g., mapping, troubleshooting, early device failure), and ultimately future CI clinical trials.
There is a critical need for better clinical decision support tools for early risk stratification and prognostication
of CI performance. Traditional approaches have shown limited success because we often focus on one or two
clinical or biological markers to stratify CI performance trajectory, hindering progress in the development of
precision medicine delivery. Second, traditional approaches have shown limited success because current
preoperative factors can only account for 10-20% of the observed variance.3,4 In response to these challenges,
we propose to develop models to support clinical decision making by (1) integrating novel biomarkers that better
account for the variability in CI performance including electrocochleography (ECochG), patient comorbidities,
and social determinants of health; and (2) utilizing artificial intelligence (AI)-based approach to analyze how
multiple clinical and biological markers interact, are associated with sub-phenotypes of CI performance, and can
be used to develop superior decision support tools / prediction models. My long-term goal is to be an independent
physician-scientist and deploy innovative and autonomous AI-based decision support tools that can seamlessly
integrate multiple variables to improve delivery of precision medicine in CI patient care. This K23 will provide
me with the protected time required to develop unique skillsets in AI-based techniques in healthcare,
quantitatively compare to modern regression techniques to understand translational clinical value gained, and
mixed methods research to improve implementation of AI-based precision medicine models. The proposed
research program addresses the mission of the NIDCD Auditory Strategy Themes 3 through 6: to promote
precision medicine approaches, to translate and implement scientific advances, to facilitate best practices in
biomedical data science, and to harness advanced technology.5

Public health relevance
PROJECT NARRATIVE Cochlear implants (CIs) are one of modern medicine’s most significant achievement; however, there remains a wide inter-individual variability of post implantation speech perception performance outcomes that cannot be predicted. The goal of this project is to develop, validate, and implement novel prediction models for CI performance that can do the following: (1) integrate novel variables that better account for sources of variance in CI speech perception performance; (2) leverage innovative computational techniques (e.g. AI/machine learning) that are not constrained by data source type and scale, for improved precision medicine delivery and the preoperative prognostication required for CI therapeutic trials; and (3) perform critical pre-implementation work so that prediction tools can be used as point-of-care models. Our preliminary data demonstrates feasibility of how such AI-based techniques alongside novel variables can potentially yield clinically actionable and generalizable insights concerning precision medicine diagnosis and care of individuals undergoing CI.